Understanding the lived experience of couples across the trajectory of dementia

Summary
Alzheimer’s disease (AD) is now frequently diagnosed in its early stages. In addition to the stressors presented
by any chronic disease, an older couple’s ability to keep their relationship intact may be undermined by the
specific and progressive symptoms of AD. Until now, most psychosocial research in dementia has focused
either on the person with AD or on the caregiver separately. Our study will focus on the relationship between
them. We will acquire qualitative data from 32 older couples (64 individuals) about the characteristics of their
relationship from the perspective of both members of the couple by conducting focus groups. We will then
recruit a culturally and racially diverse sample of older adult couples [300 older adult couples (600 individuals)],
the members of which will range from cognitively normal through early dementia at baseline. Follow-ups will
occur at 6 month intervals for three years (six assessments) and include both members of the couple through
the early stage of Alzheimer’s disease and only the caregivers when participants transition to the middle and
late stages. We include cognitively normal couples to serve as a reference group, to enable an understanding
of change. Our psychosocial assessment includes measures of cognitive function, activities of daily living and
behavior, as well as social support, coping, mental health and self-rated physical health, as well as time to
transitions such as residential care placement. The information we obtain will be used to conduct both cross-
sectional and longitudinal analyses, develop typologies of relationships, and enable us to investigate the effect
of these relationship types on outcomes such as emotional and physical health of both members of the couple,
as one member becomes increasingly impaired by Alzheimer’s disease. By following the couples over time, we
will be able to track changes in relationship style along with change in cognitive, functional and behavioral
status, social support and health outcomes. We will develop tentative typologies and a causal model based on
baseline data. The longitudinal study will enable us to corroborate or refine the model and elucidate the
relationship styles and changes that are most likely to maintain the well-being of both members of the couple.
In our prior experience, the most powerful mediator of outcome is social support, and we plan to see what role
that plays in mental and physical health outcomes in this study as well. We expect to find that as dementia
advances, the well spouse will have to modify his or her expectations for support from the ill spouse, and that
there will be better outcomes if s/he has more satisfactory emotional support from others, particularly family
members. The results of this study will include the development of statistical models, and descriptions of
couple typologies that will enable us to design interventions to help couples to adapt successfully and minimize
the negative effects of Alzheimer’s disease on their relationship and on health outcomes and care cost.

Public health relevance
Project Narrative This study will enable development of new psychosocial interventions for older adult couples to help them withstand the impact of cognitive, behavioral and functional decline associated with Alzheimer’s disease. By studying couples over time, we will learn about the impact of Mild Cognitive Impairment and Alzheimer’s disease on their relationships, and the extent to which certain relationship styles are protective against the negative impact of Alzheimer’s disease on the mental and physical health of both members of the couple. With the increasing numbers of couples expected to be affected by AD in the future, widespread availability of effective psychosocial interventions to mitigate the impact of the disease can have a major public health impact.